TRANSIENT SPECTROSCOPY OF TETRAPHENYLPORPHYRINS

As an adjunct to our previous studies of transient absorption and resonance Raman studies on Cu tetraphenyl porphyrins (CuTPP), we are interested in the spectroscopic properties of Ni2+ and Ru2+ substituted porphyrins, where the substituents are expected to alter the charge density on the porphyrin ring structure and hence the charge transfer and metal centered excited states.